Data Management, Analysis, and Resources Dissemination Core

Data Management, Analysis, and Resources Dissemination Core summary
The Broad Institute’s Genomic Center for Infectious Disease (GCID) will continue to apply its deep experience
in large-scale genomic analysis to study the virulence, transmission, and drug sensitivity of pathogens as well
as their critical interactions with hosts, vectors and other microbes. Achieving this will require combining data
sets from diverse technologies with bioinformatics capabilities and computational analyses. The Broad GCID
will draw on its expertise building and maintaining efficient computational processes and computational
infrastructure to create a robust Data Management, Analysis, and Resources Dissemination Core. The Core
will support our Research Projects with high-throughput sample tracking, metadata and data management,
large-scale analysis, development of novel computational methods, and the rapid release of high quality data
and associated resources. Our Data Core will harness the extensive technological capabilities of the Broad
Institute and the vast experience of our personnel in genomic research to serve the ambitious goals of our
Research Projects. The Core will also maintain a program of ongoing method development tied to innovations
in the Technology Core and the goals of the Research Projects; these include methods for strain analysis in
metagenomic samples, improved quality control analysis of sequence data, updating assembly methods to use
long read- and hybrid-data, customized 10x Genomics data applications, analysis of horizontally transferred
sequences, methods for Tn-Seq analysis, and training and evaluating new methods for variant calling. These
methods are cross-cutting across our Research Projects and will be widely applicable to genomic infectious
disease research. In addition to releasing data to public repositories, the Data Core will continue to move
pipelines, processes, and data sets to the cloud, to accelerate the infectious research community’s access to
our data and tools and enable others to reproduce our analyses.